Exploring Wolbachia for malaria control

SUMMARY
Malaria exerts a heavy public health burden, and the emergence of insecticide-resistant mosquitoes and
drug-resistant parasites, along with the lack of a broadly effective vaccine, necessitates the development of new
methods for disease control. While Wolbachia has been successfully developed for arbovirus control and
shown a promising potential for malaria control, the limited choices of Wolbachia-transinfected Anopheles
mosquitoes and the lack of knowledge on how external environmental factors and both mosquito and parasite
genotypes may influence Wolbachia-mediated parasite-blocking, along with a lack of understanding of the
blocking-mechanism, are remaining hurdles for the development of effective Plasmodium transmission-
blocking approaches. Compared to other mosquito biological control strategies, Wolbachia-based population
replacement is advantageous because it has the potential to provide sustainable disease control at a relatively
low cost. To date, only a single Wolbachia transinfected anopheline line has been published, with the
establishment of the wAlbB strain in Anopheles stephensi, and this transinfection confers a greater resistance
to infection with Plasmodium. We aim to develop novel Wolbachia transinfected lines with enhanced
Plasmodium suppressing effect (Aim 1), tolerance to high temperature, and minimal fitness costs, and assess
how external environmental factors influence both Wolbachia infection and its ability to block Plasmodium
infection (Aim 2) and how both mosquito and parasite genotypes may influence Wolbachia-mediated parasite-
suppression and whether the mosquito’s REDOX system is a determining blocking-mechanism (Aim 3).
Importantly, this project will develop new tools such as novel Wolbachia transinfected Anopheles lines, and
further our knowledge on crucial factors for Wolbachia symbiosis with the Anopheles mosquito vector, and
mechanisms involved in Wolbachia-mediated Plasmodium suppression, thereby facilitating the development
of Wolbachia-based biocontrol strategies.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project will develop new tools and study Wolbachia-mediated Plasmodium suppression in Anopheles mosquitoes, and how it can be influenced by a variety of field-relevant factors. The project will thereby assess the potential of using Wolbachia as a malaria control strategy.